Exercise Therapy for Advanced Lung Disease Trials: Response and Adaptation to Aerobic Exercise in Patients with Interstitial Lung Disease

AET is generally safe, inexpensive, and can easily be made available and accessible to almost everyone. It requires no approval by regulatory agencies and is thus available as a medically prescribed and supervised intervention almost immediately following confirmation of its safety and efficacy. Six-minute walk distance is associated with improved HRQoL in patients with ILD and in specific subsets. Effective use of AET as a rehabilitative intervention could have a high degree of impact on personal and public health outcomes in this advanced lung disease subset. Total Number of Subjects Screened=161 Total Number of Subjects Enrolled = 28 Total Number of Subjects Enrolled in the current year = 4 Total Number of Subjects Enrolled that dropped this year =0 Number consented (including screen failures and withdrawals/dropouts): over the life of the protocol = 42 since last CR = 6 (4 subjects are considered enrolled as having completed randomization; 2 subjects were not enrolled due to screen failure - see below) The 2 subjects who were consented to the study but were not enrolled due to screen failure: One patient was screen failure due to pulmonary hypertension One patient withdrew due to family emergency